Role of physical training and intraspinal hemodynamic changes in the recovery of forelimb function after cervical spinal cord injury in rats

Project Summary
This request for an administrative diversity supplement award will allow Mr. Hernandez to develop
as a scientist and gain additional training and skills needed to be competitive candidate into a
PhD program in Physical Therapy. Mr. Hernandez will work with Dr. Khaing (mentor), Dr. Bruce
(co-mentor), and Dr. Chet Moritz (co-mentor) to learn and develop skills to complete a successful
research project. Mr. Hernandez proposed to develop a project examining 1) the combined effects
of physical therapy and a neuroprotective agent (Glibenclamide), and 2) altered blood flow within
the chronic spinal cord after cervical spinal cord injury. This project is within the scope of the
parent R01 grant because it aims to explore how to obtain optimal functional recovery by
combining neuroprotection (proposed in the parent R01) with physical therapy training.
Additionally, this project will also utilize the novel ultrasound imaging technique proposed in the
parent R01 to explore the alterations in intraspinal blood flow changes that may mediate or
correlate with improved functional recovery in a rat model of spinal cord injury. We hypothesize
that rats that receive physical training and Glibenclamide will be able to perform forelimb reaching
tasks (FRT) more effectively when compared to other groups treated with physical training or
Glibenclamide alone. Specifically, we will test whether functional recovery of forelimbs can be
enhanced with a physical therapy/training intervention. Recently our lab has successfully
developed contrast-enhanced ultrasound (CEUS) for use with rodent traumatic SCI. Here will
utilize acute and transcutaneous B-mode and contrast enhanced ultrasound (CEUS) imaging to
perform a longitudinal study in control and treatment groups to determine hemodynamic
changes associated with improved functional recovery after cSCI. Through this proposed
study, Mr. Hernandez will receive training on designing and executing a research project, sterile
surgical techniques, ultrasound imaging techniques as well as histological techniques to
accomplish the proposed work. Additionally. Mr. Hernandez will receive training in MATLAB for
image acquisition, processing and data analysis using this program. Mr. Hernandez will receive
mentoring from Drs. Khaing, Bruce, and Moritz on experimental design, execution as well as data
analysis, interpretation, and manuscript writing skills. Mr. Hernandez will also be expected to
present the findings from this project at a national or international meeting to gain additional
exposure and networking opportunities. Finally, Mr. Hernandez will be encouraged to develop his
own research ideas to be developed as F31 in the future.

Public health relevance
PROJECT NARRATIVE Mr. Hernandez’s career goal is to enter a PhD program in Neurorehabilitation and Physical Therapy and obtain at Doctor of Physical Therapy. Mr. Hernandez will be mentored to develop and execute a research project examining the combinatorial effects of physical training and a neuroprotective agent on forelimb functional recovery after cervical spinal cord injury as well as receive mentorship to facilitate his successful entry into a competitive PhD program.